LEARRN: Promotion of Center Expertise Component

PROJECT SUMMARY
The Promotion of Center Expertise Component will develop and implement a variety of activities to promote
interest in LeaRRN and LHS research in rehabilitation. The specific aims of this Component are to: 1)
coordinate the development and dissemination of all products (manuscripts, abstracts and reports), training
and resource materials and training opportunities to engage target audiences; 2) facilitate dissemination of
news, announcements and findings resulting from LeaRRN activities to target audiences through Newsletters,
press-releases and email marketing and social-media campaigns; 3) oversee the establishment of a Center
website that highlights activities, resources and dissemination activities and is designed to provide users with
easy access to content targeted to meet their LHS learning needs; and 4) assist in recruitment of Pilot
applicants, LHS Scholars and in promotion activities for webinars, grand rounds, Institutes as well consultative
services at national conferences and ensure that target audiences are engaged. This component will be led by
Drs. Mary Slavin and Linda Resnik and will be assisted by the Program Manager at Brown University and the
Program Assistant at BU. Dr Resnik will insure that dissemination and recruitment efforts are comprehensive
and timely. Dr. Slavin will leverage resources within the Boston University’s College of Communications,
including AdLAB, a faculty mentored, student run advertising agency to develop effective communication
products. BU Productions, a professional production company located at BU, will support our webcasts and
post-production development to yield high-quality videos to archive. The Promotion of Center Expertise
Component will publicize LeaRRN activities and resources, and develop web-based resources (e.g., archive
webinars, webcasts) to engage the medical rehabilitation community the LeaRRN activities and resources.
This Component will also disseminate research and presentations resulting from activities conducted by
LeaRRN LHS Scholars and the Pilots and Techniques Components. LeaRRN recognizes the need to increase
the diversity of the rehabilitation research workforce and will make a concerted effort to expand our
connections to members of the rehabilitation community that have not typically been engaged in research
activities. Our promotion and outreach activities will target persons with disability, and those from underserved
regions with limited opportunities to participate in our Institutes, Pilot and LHS Scholar program. A significant
advantage of our approach is that we will be engaging frontline clinicians as an important part of the research
endeavor. Outreach activities will ensure that LeaRRN has a sustained, powerful influence on the broader
rehabilitation community.